Project-008

The University of Texas Medical Branch (UTMB) has participated as a CTSA hub since 2009. The academic home
of our CTSA, the Institute for Translational Sciences (ITS), has brought together multidisciplinary translational
teams (MTTs) and the resources necessary to accelerate discoveries toward better health for individuals and
communities. Building on our existing strengths, CTSA initiatives have transformed UTMB’s learning and research
culture to one that embraces multidisciplinary translational team (MTT) approaches to addressing significant
health problems. We have developed novel educational curricula, significant clinical research programs in
special populations with multisite clinical trials, and provided leadership in the Texas Regional CTSA consortium
(TRCC) and nationally. UTMB’s CTSA hub supports the health goals of the nation by generating, testing and
disseminating integrative team science, education and best practices through stakeholder involvement at all
stages. Managed by a continuous improvement model using an Innovation Scorecard, we will address six
specific aims, to: 1) Expand the knowledge base and practice of collaborative teams to advance the conduct
of translational research through team-based innovation. Building on our team science leadership, we will test,
learn, and disseminate multi-institutional teaming to enhance the quality, efficiency, effectiveness, and diversity
of clinical and translational research. 2) Engage local, regional, and national stakeholders to make research more
effective at meeting their needs. We will build upon our relationships to extend inter-institutional partnerships, and
to work with stakeholders to disseminate scientific findings and advance the field of community engagement. 3)
Harness the potential of harmonized large data platforms across the translational spectrum to improve research
efficiency, develop technologies to support research teams, and share resources with researchers across the
CTSA network. Our aims are designed to enhance our informatics infrastructure and training with regional and
CTSA network interoperability putting existing and novel analytics tools into the hands of users. 4) Promote
clinical and translational research across the lifespan including special populations. We will expand upon our
significant strengths in multi-site trials in special populations to proactively engage the NCATS Trial Innovation
Network for new trials originating from UTMB. 5) Improve training for a diverse workforce in the authentic skills
needed to advance all phases of clinical and translational research. Our integrated U, K, and T programs will
include participants with diverse professional and educational experience, as well as diverse age, gender, racial,
and ethnic characteristics. 6) Develop and disseminate improved methods and processes for translation from
discovery to improved health. We will apply a continuous improvement approach to understand barriers, develop
effective interventions, and disseminate improvements in translational science and operations.